Genomics of spermatogenic impairment

PROJECT SUMMARY
This is a renewal application to the NICHD-funded Genetics of Male Infertility Initiative (GEMINI) established
under R01HD078641. In the past funding period, we added key knowledge to our understanding of Mendelian
forms of nonobstructive azoospermia (NOA). Through GEMINI, we have successfully navigated the intricacies
of establishing and engaging valuable clinical collaborators, exceeding recruitment goals. In addition, we have
developed and refined powerful software to map genetic causes for n=1 cases of NOA, and in so doing have
successfully identified a large number of novel loss-of-function variants responsible for the disease.
Characterization of the underlying genetic basis for severe spermatogenic impairment is critical for its
implications in improving diagnosis and treatment in reproductive medicine. Improved understanding of genetic
causes of male infertility may have broader implications for the health of affected men. Abundant
epidemiological data indicate that male infertility is a risk factor of developing other comorbidities including
various types of cancer, cardiovascular disease, diabetes and overall reduced general health. While we expect
that GEMINI will continue to uncover new infertility mutations with diverse methods of action, we will unify our
research in this cycle around the central theme of “comorbidity”. We hypothesize that the epidemiological
association between male infertility and diseases such as cancer may be caused by variants underlying
spermatogenic impairment and the increased burden of mutations in infertile men. The central goal of the
project is to continue to identify new Mendelian forms of severe spermatogenic impairment and additional
alleles in known and suspected male infertility genes. This genetic discovery will be driven by exome
sequencing of a new cohort of 1000 men with severe spermatogenic impairment and 1000 men with normal
semen parameters. Drawing upon lessons from the first phase of GEMINI, we are proposing a number of
additions to our approach, including new statistical methods and functional assays of primary tissue from
cases, and new collaborations for replication and model organism studies. We will apply the analytical tools
developed under R01HD078641 to identify potential infertility variants from publicly available genomes,
including over 500,000 that will be available through the UK Biobank (UKBB), the eMERGE Network, and the
Utah Genome Project (UGP). The rich phenotypic resources from these biobanks will be used to perform both
phenome-wide association studies (PheWAS) and more targeted analyses to identify genetic links between
infertility and both known and novel comorbidities. Successful completion of these aims will significantly
improve our understanding of the genetic basis for spermatogenic impairment and the basis for the observed
relationship between male infertility and other comorbidities, with the overarching goals of improving male
infertility diagnosis and treatment as well as improving our capacity to risk-stratify infertile men based on their
likelihood of developing specific comorbidities later in life.

Public health relevance
Project Narrative Despite its societal importance, and prevalence as high as 5-7%, the underlying etiology of male infertility is unknown in up to half of infertile men. With an improved understanding of the genetic causes of male infertility, patient genetic information will transform the way that male infertility is diagnosed and treated. Our international, multicenter study of male infertility genetics will build the resources necessary to bring male infertility care into the era of personalized genomic medicine.